Non-Opioids for Inflammatory Pain: Adenylyl Cyclase 1 as a Novel Target

ABSTRACT
Chronic pain is a major concern in public health with financial costs projected to surmount $600 billon in the
next year. Patients afflicted with chronic pain endure extreme emotional, physical, and social burdens,
resulting in severely diminished quality of life. Unfortunately, drugs currently used for chronic pain
management, such as NSAIDs, opioids, neuronal stabilizers, and antidepressants, do not typically provide
sufficient relief to restore full quality of life, and in many instances these treatments themselves limit
patients, such as opioid treatment preventing a patient from legally driving. Recent preclinical studies have
identified neuronal adenylyl cyclase type 1 (AC1) as a novel target for treating chronic pain. AC1 is highly
expressed in neuronal tissues associated with pain processing and neuronal plasticity, and studies using
AC1 knockout mice provide direct evidence linking AC1 to chronic inflammatory pain conditions.
Furthermore, AC1 inhibitors would lack the side effects associated with other agents (e.g. opioids) used to
treat chronic inflammatory pain. The development of AC1 inhibitors represents a unique challenge, as
demonstrated by a prior preclinical AC1 inhibitor, NB001. NB001 has significant shortcomings, including
modest selectivity over other adenylyl cyclase isoforms, likely due to its adenine-like structure. Compounds
of this type are called P-site inhibitors and act by binding to the active site of AC that is conserved among all
isoforms. Additional concerns for adenine-containing molecules like NB001 include effects on other cellular
processes such as DNA synthesis. We hypothesize that developing a small molecule inhibitor of AC1 will
allow us to mimic the AC1 knockout phenotype and provide a new avenue for the treatment of chronic
inflammatory pain. We designed our studies to target NOT the conserved P-site or forskolin-binding site, but
rather a novel approach, targeting the unique protein-protein interaction of AC1 and calmodulin (CaM). AC1
and AC8 are both activated by CaM, however, the CaM binding domains are unique in structure and
location providing an unprecedented opportunity to achieve AC1 selectivity. Thus, the goals of this proposal
are to: 1) develop a novel AC1/CaM biochemical screening assay, 2) implement this novel assay in a high
throughput screen to interrogate a library of 100,000 compounds for inhibitors of the AC1/CaM protein-
protein interaction, and 3) validate and chemically optimize lead molecules using cellular assays focused on
selectivity and potency to guide medicinal chemistry efforts. To date, we have completed initial studies to
develop the novel screening assay, established a subset of the necessary assays, and cemented the
collaboration between the University of Iowa and Purdue University for the successful completion of our
aims. We anticipate the identification of selective AC1 inhibitors that ultimately be improved and applied in
models of chronic inflammatory pain.

Public health relevance
Project Narrative This proposal focuses on the development of a high throughput screen and subsequent characterization and medicinal chemistry of newly discovered molecules that act as inhibitors of the adenylyl cyclase 1 and calmodulin protein-protein interaction that may provide a new avenue of treatment for chronic inflammatory pain. Given the tremendous social and economic burden associated with chronic pain conditions, and the fact that most current treatments have severe side effects, there is a need for a new approach in treating chronic pain. This study will explore the exciting new target of the adenylyl cyclase 1/calmodulin interaction, which prior data suggest will be efficacious, as well as have fewer harmful side effects.